Brain structure and function in adult ZIKV patients with neurological manifestations

Project Summary Since its recent outbreak in the Americas in 2015, Zika virus (ZIKV) has become a major global health threat due to its potential to affect the nervous system. An estimated 3-4 million people have been infected by the mosquito-transmitted ZIKV since 2015. While most cases show no or only mild symptoms, some adult patients exhibit severe neurological complications including symptoms of the central nervous system. To date, there are no functional neuroimaging studies to unveil where and how ZIKV affects human brain function at the systems level. Reports of structural brain changes in adults have remained largely confined to few single cases, and the relation between structural and functional brain changes remains unknown. Unless this crucial knowledge gap is closed, the understanding of disease course, outcomes and mechanisms of ZIKV neurological complications in adults will remain incomplete. Consequently, an important opportunity to inform development of treatments in adults, as well as providing insights about potential mechanisms in infants, will be missed. The objective of this proposal is to establish the course of structural and functional changes in the brain of adults with ZIKV- related neurological complications. The central hypothesis is that ZIKV patients with central nervous manifestations show changes in brain structure and function linked to CNS inflammation. This hypothesis has been formulated on the basis of our preliminary neuroimaging data acquired in the Dominican Republic, suggestive of regionally specific changes in gray matter volume and functional network connectivity. We seek to accomplish our objective by conducting a longitudinal study (in acute, subacute and recovery phases) using structural and functional Magnetic Resonance Imaging in 25 ZIKV patients with central neurological manifestations, 25 ZIKV patients with neurological complications of the peripheral nervous system only, and matched healthy controls. In Specific Aim 1, we will identify local changes in gray matter volume and white- matter integrity caused by ZIKV. Specific Aim 2 will identify changes in intrinsic functional and structural connectomes caused by ZIKV. Finally, Specific Aim 3 will determine the association of structural and functional changes with ZIKV-related neurological manifestations. This program of research responds directly to NIH’s call to study ZIKV complications (Funding Opportunity Announcement PA-17-085). The expected outcomes would establish that ZIKV can affect the adult human brain, thus explaining how neurological complications of ZIKV extend beyond the peripheral nervous system and cause central manifestations. Once the course of structural and functional changes of ZIKV neurological manifestations are identified, more targeted efforts for development of treatments will become possible, and new avenues for translational investigations, e.g. into the pathophysiology of ZIKV, will open.

Public health relevance
Project Narrative Since its recent outbreak in the Americas in 2015, Zika virus (ZIKV) has become a major global health threat due to its potential to affect the nervous system, yet to date there are no group-level neuroimaging studies to unveil where and how ZIKV affects human brain function at the systems level. The objective of this proposal is to establish the course of structural and functional changes in the brain of adults with ZIKV-related neurological complications. This proposal has the potential to provide valuable information about the natural history of ZIKV, and may provide insight for more targeted development of treatments for the disease.